MODULATION OF CD5 SIGNALING TO ENHANCE ADOPTIVE T-CELL THERAPIES FOR CANCER

PROJECT SUMMARY
Adoptive T-cell immunotherapies and, in particular, chimeric antigen receptor T cells (CART) generated
unprecedented responses in patients with highly refractory CD19+ B cell malignancies. However, only a limited
number of patients treated with anti-CD19 CART will experience prolonged remission while most patients either
do not respond or eventually relapse. Moreover, in the setting of solid cancers, CART cells have generally been
disappointing. Increasing CART effector function against cancer would represent a vertical improvement in the
field of adoptive T-cell immunotherapy. In this proposal, we aim at increasing the anti-tumor efficacy of CAR T
cells by reducing the inhibition of CAR activation. Current approaches to enhance CART efficacy focus on
reducing long-term T cell exhaustion by targeting the PD-1/PD-L1 axis. However, there is a lack of investigation
on strategies to enhance early CAR and T cell receptor (TCR) signaling, which is critical for effective tumor killing,
especially in the setting of the immunosuppressive tumor microenvironment. To this goal, we studied the
scavenger receptor CD5. CD5 associates with the TCR complex and inhibits its activation through several
mediators, including SHP-1, CBL, CBL-B, and GRB2. The central hypothesis of this grant is that CD5 deletion
increases the anti-tumor efficacy of engineered T cells through enhancement of TCR signaling. In our preliminary
work, we have found that CRISPR-Cas9 CD5 knock out in CART cells enhances their anti-tumor activity in
xenograft models of B-cell leukemia (CART19) and T-cell lymphoma (CART5). Moreover, we demonstrated that,
upon stimulation, CD5 knocked-out CART cells show higher phosphorylation of key CAR signaling mediators as
compared to wild-type. In Aim#1, we will test the hypothesis that the deletion of CD5 in T cells broadly enhances
the anti-tumor efficacy of adoptive T-cell immunotherapies, by studying CD5 knockout in the setting of CAR T
cells for solid tumors. In Aim#2, we will test the hypothesis that CD5 deletion augments T-cell anti-tumor activity
by disinhibiting CAR signaling by performing in vitro and in vivo mechanistic studies. We will also test the safety
of this approach. This hypothesis-driven proposal is highly innovative as it proposes the study of a novel
immunomodulatory target - CD5 - and uses cutting edge technologies like digital spatial profiling and single-cell
RNA sequencing to investigate CD5 deleted CAR T-cell in vivo in both human and murine models. A successful
outcome of the proposed investigations is expected to impact the field of cancer immunotherapy significantly,
providing a rational and generalizable approach to improving T-cell immunotherapies and ultimately drive the
development of a first-in-human clinical trial of CD5 knocked-out CART for refractory cancers.

Public health relevance
PROJECT NARRATIVE This proposal seeks to enhance the potency of adoptive T cell immunotherapies and chimeric antigen receptor T cells (CART) against cancer by removing a key inhibitory factor, CD5, from T-cells. The proposed research is highly relevant to public health because CART immunotherapy, despite being now routine clinical practice, still fails in a significant subset of patients. The project is relevant to those parts of the NCI’s mission that pertain to the treatment of cancer, and the advancement of scientific knowledge and help all people live longer, healthier lives.